Genetic Basis of Virulence of Community MRSA Clone USA300

[unreadable] DESCRIPTION (provided by applicant): Staphylococcus aureus is a major human pathogen. It can cause rapidly fatal infections. A highly virulent clone of methicillin resistant S. aureus (MRSA), USA300, is epidemic in communities in the United States. MRSA is resistant to all antibiotics chemically related to penicillin, thus emergence of this clone is a serious public health issue. Our research objective is to identify genes that contribute to virulence of USA300. Emergence of USA300 is associated with acquisition of certain mobile genetic elements, which we suspect carry genes that impact virulence. To test this hypothesis, mutants of USA300 in which suspected virulence genes have been deleted will be tested in rabbit infection models and in vitro assays to determine if their virulence is reduced compared to the normal strain. Polymorphonuclear neutrophils (PMNs) are the first line of innate host defense against S. aureus infection and are critical for bacterial clearance. PMN function will be assayed in vitro to determine whether virulence factors affect human PMN chemotaxis, phagocytosis, or bacterial killing. Specific aims are: 1) To identify virulence determinants in the arginine catabolic mobile element (ACME), which is unique to USA300. Deletion of ACME reduces virulence. Three "likely suspect virulence genes, arcA, opp-3A and opp-3DF, will be deleted and each mutant tested to determine which impact virulence. 2) To determine whether SOS response induced by non-lethal exposure to beta-lactam antibiotic generates adaptive mutations offering a survival advantage to MRSA. 3) To determine if disruption of PVL genes attenuates virulence in a rabbit pneumonia model. PVL (Panton-Valentine leukocidin) is generally assumed to be the most important virulence factor in USA300, but this is highly controversial. The rabbit as a species is sensitive to PVL and lung may be target organ. Results from this model should help resolve the controversy as to whether PVL is a major virulence factor. 4) To determine whether genes within two other elements, (Sa3 prophage and SaPI5 pathogenicity island, encode virulence determinants. Relevance: Emergence of virulent, drug-resistant strains of S. aureus in the community is a public problem second only to AIDS in scope and importance. Defining genes contributing to the special virulence of USA300 strains is a critical first step for developing new drugs and approaches for treatment of severe infections caused by community-associated MRSA strains. PUBLIC HEALTH RELEVANCE Antibiotic resistant strains of Staphylococcus aureus, an important human pathogen, are on the rise. One particular clone, USA300, seems to be especially virulent. Several genes that could be important for virulence are uniquely present in USA300. By knocking each of these genes out and testing for loss of virulence, we hope to learn which genes code for virulence. Once these genes are identified, strategies to block their effects may be developed. [unreadable] [unreadable] [unreadable]